Antigen Presentation by B Cells in T Cell Mediated Autoimmunity

Experimental autoimmune encephalomyelitis (EAE) is an animal model that reproduces many of the clinical and pathological features of multiple sclerosis (MS). While it is well documented that myelin specific T cells, Th1 and Th17 cells are important for the initiation of the disease, the role of B cells and antibodies in the disease process is not well understood. The development and the progression of EAE, like other autoimmune diseases, results from the pathogenicity of effector T cells and the negative regulation imposed by regulatory T cells (Tregs). However, the lack of a reliable marker for regulatory T cells has made it difficult to study the interplay between myelin specific effector T cells and regulatory T cells. To study the effect of antigen specific B cells in the generation of pathogenic T cells, we have established a mouse model (2D2xTH mice) in which both T and B cells are specific for the same myelin protein, myelin oligodendrocyte glycoprotein (MOG). The majority of 2D2xTH mice (about 59%) develop a very severe form of spontaneous EAE within 6 weeks of age that is similar to a sub-form of MS called Devic disease, characterized by the presence of inflammatory foci restricted to the spinal cord and optic nerve. By gene expression profiling, we have identified IL-22 as a cytokine differentially upregulated in the spinal cord of mice with Devic disease. We have also generated a Foxp3-EGFP knock-in mouse in order to track CD4+CD25+ Treg cells during the course of an ongoing immune response. With the help of l-Ab/MOG35-55 tetramer (developed in collaboration with Kai Wucherpfennig) we are able to track development and effector functions of MOG specific pathogenic and regulatory T cells. Based on our results, we propose that antigen presentation by MOG-specific B cells generates highly pathogenic T cells and limits the generation and function of MOG specific CD4+CD25+ regulatory T cells which results in the development of a very severe EAE. We will test whether: 1) MOG specific B cells participate in disease progression by the secretion of MOG specific pathogenic antibodies and /or by preferential antigen presentation to MOG-specific T cells; 2) T cells generated in the presence of cognate antigen specific B cells are more encephalitogenic and produce more IL-17 and IL-22; 3) MOG specific B cells limit the expansion and/or function of regulatory T cells responsible for keeping pathogenic T cells under check. The role of IL-22 in generating highly pathogenic T cells and development of Devic-like disease in mice will be evaluated by using IL-22 deficient mice. The proposed studies will allow us to better characterize the mechanism by which autoantigen specific B cells induce autopathogenic T cells and how they regulate the expansion and function of antigen specific regulatory T cells. Furthermore, our proposed studies will allow us to study how antigen specific B cells might control the development of an organ specific T cell mediated autoimmune disease.